ABT 538 VS AZT VS ABT 538 AND AZT IN HIV+ PATIENTS WITHOUT PRIOR THERAPY

The objectives of this study are: 1. to evaluate the safety and antiviral activity of monotherapy with ABT-538 at a dose of 600 mg. BID, monotherapy with AZT at a dose of 200mg. TID and a combination therapy with ABT-538 and AZT in HIV infected patients; 2. to study emergence of resistance to ABT-538. All patients participating in this trial will be allowed to cross over to the ABT-538 arm of the trial and will be continued to be monitored for virological data.